Structural characterization of interacting and aggregating cataract-associated crystallins

Project Summary Cataracts are the leading cause of blindness in the world, with approximately 22 million cases per year. The disease is caused by protein aggregation in the eye lens, involving its major constituents, the crystallins. Currently, the only available treatment is surgery, widely used in the developed world. However, access to surgery is not available to a significant fraction of the world population, and, as with any surgery, complications may ensue. Therefore, it is important to provide a structural understanding of cataract formation, if novel therapeutic approaches are to be developed for delaying the onset or slowing the progression of cataracts. While the congenital form of the disease has been mapped to crystallin gene mutations, the age-related degenerative disease is believed to involve chemically-modified crystallin proteins. Previously, we investigated the dynamics, structure and folding of human gD-crystallin mutants that are associated with congenital cataracts. We solved NMR and X-ray crystal structures of several variants and analyzed their dynamic behavior by solution NMR spectroscopy. Our aim now is to elucidate the interactions between different crystallins, under physiologically- relevant high concentrations. We will investigate proteins with modifications that mimic aging and using congenital cataract-associated mutants. We hypothesize that surface changes that impact the liquid phase behavior of the crystallin and/or generate aberrant protein-protein interactions contribute to aggregation. Our studies will not only provide insight into the process of cataract formation but also will shed light on fundamental questions in protein science. Although biochemical and biophysical studies have provided a detailed picture of individual crystallin structures and stability, extensive studies are needed to assess the interplay between different crystallin proteins and, thereby, provide critical data on crystallin structure/function relationships. For example, the interactions that permit high protein concentrations in lens cells and questions about which, why, and how certain crystallins interact without aggregation in the normal lens require direct experimental studies to gain new insights. In addition, several post-translational modifications have been reported to occur upon lens aging, impacting lens transparency. Whether and how such aged crystallins contribute to protein stability and aggregation is unknown. The proposed research will address these outstanding issues through biophysical analyses of wild-type, disease-associated, and chemically-modified, “aged”, crystallin variants. Structural studies by solution and solid-state nuclear magnetic resonance (NMR) spectroscopy, small angle x-ray scattering (SAXS), and electron microscopy methods will be used to directly investigate different crystallin mixtures to obtain novel insights into the behavior of normal assemblies involving lens-opacity associated proteins. Structural details of such assemblies cannot be obtained by any other methodologies.

Public health relevance
Project Narrative Worldwide, more than 250 million people suffer from impaired vision or blindness, the majority of which is caused by cataract. At present, the only available treatment is surgery; however, a significant fraction of the population in the US and elsewhere is unable to access surgery for various reasons. Fundamental understanding of the mechanisms of cataract formation will open the way to develop new therapies that delay the onset or slow down progression of the disease.